Odor Coding in the Dorsal Tenia Tecta

PROJECT SUMMARY
The formation of a percept results from the processing of sensory information across a network of brain
regions, each contributing uniquely to perception. Thus, to understand the mechanisms by which the brain
encodes sensory information, we must study each component of the network. Olfactory perception is dependent
upon a distributed network of processing centers, which are connected in serial and parallel manners. Odor
information is organized into receptor-specific channels mapped onto the olfactory bulb. These singular streams
of information are broadly projected by mitral/ tufted cells to multiple cortical structures. This direct, parallel input
is thought to allow each region to maintain a representation of the stimulus and play a unique role in odor
perception. While putative functions have been ascribed to several olfactory cortical regions, the importance of
the dorsal tenia tecta for olfactory perception remains a mystery. Here, we propose to examine the connectivity,
odor coding, and function of this region. Specific Aim 1 will examine the afferent and efferent connections of the
dorsal tenia tecta. Specific Aim 2 will characterize the odor tuning properties of dorsal tenia tecta neurons.
Specific Aim 3 will assess the contribution of this region for olfactory perception. Achieving these aims will provide
new insight into how odorant features are encoded and mapped within the brain and elucidate the function of
this enigmatic brain region for olfactory perception.

Public health relevance
PROJECT NARRATIVE The olfactory system allows humans to evaluate the quality of food sources and to avoid harmful chemicals, thereby promoting overall health and quality of life. Relatively little is known about how higher order brain structures process olfactory information in mammals. We are using a combination of different techniques to understand the importance of an understudied brain region, the dorsal tenia tecta, for olfactory perception.